HORMONAL REGULATION OF ANGIOTENSIN RECEPTORS

Once women enter menopause, they lose their protection from hypertension, cardiovascular disease and progressive renal disease when compared to age-matched premenopausal women and age-matched men. In the first funding period, we found that experimentally mimicking the state of menopause by ovariectomy in several species, increased the density of angiotensin type 1 receptors (ATiR) in the adrenal and kidney, which are two key target tissues of the renin angiotensin system (RAS) that are critical to the control of blood pressure. Furthermore, increased ATiR numbers resulted in increased sensitivity to angiotensin II (Ang II) in both these tissues. In pathological models of aging and hypertension associated renal disease, estrogen deficiency was associated with increased renal injury, including interstitial fibrosis and glomerulosclerosis, and increased NAD(P)H oxidase activity, which was prevented by 17p-estradiol ([unreadable]2) replacement. We also recently found that [unreadable]2deficiency reduced the expression of the newly discovered member of the RAS,namely, angiotensin converting enzyme 2 (ACE2), which hydrolyzes Ang II to the vasodilator heptapeptide, Ang-(l-T). The actions of ACE2 are thought to counter those of ACE.In fact, ACE2 has been shown to be cardioprotective in the heart;however, much less is known regarding the role of ACE2 in the kidney. In this competitive renewal, we will focus on the signaling pathways leading to tubulointerstitial fibrosis (TIP) in the unilateral ureteral obstruction model (UUO) in the mouse, which is a widely used model of accelerated TIP.The RASplays a major role in these signaling pathways since angiotensin converting enzyme (ACE) inhibitors and ATiR antagonists are widely used clinically to inhibit disease progression in these pathologies. We will investigate [unreadable]2 regulation of ACE-dependent (Aim1), ATiR-dependent (Aim 2) and ACE2-dependent (Aim 3) pathways in the pathological processes leading to TIP that contribute to the renal protection afforded the estrogen replete female. In a mouse model of UUO,we will test the hypothesis that [unreadable]2 loss in the obstructed kidney promotes TIFby increasing renal oxidative stress through augmentation of ACE- and ATiR-dependent superoxide (Or) accumulation and attenuation of ACE2-dependent inhibition of superoxide accumulation through nitric oxide (NO) generation;[unreadable]2 loss also promotes TIP by stimulating extracellular matrix accumulation through increased ACE-and ATiR-dependent transforming growth factor pi (TGF-pl)-Smad signaling pathways. The signal transduction pathways leading to TIPin UUO share many similarities with a number of chronic renal diseases of various etiologies. Thus, specifically investigating the RAS-dependent mechanisms underlying the effects of [unreadable]2 loss on TIP progression in UUO may lead to a greater understanding of the mechanisms involved in progressive renal disease in postmenopausal women and ultimately, may lead to the development of novel therapeutics for treating this major public health problem in both men and women.